Transcriptomic and Proteomic Analysis of Tau-dependent E/I Imbalance

SUMMARY
Evidence for excitation/inhibition (E/I) imbalance of neural networks has been found in diverse brain disorders
that are prevalent, devastating, and refractory or poorly responsive to available therapies, including Alzheimer’s
disease (AD), epilepsy, and autism spectrum disorders. In animal models for these conditions, reducing overall
levels of non-aggregated, endogenous, wildtype tau prevents or diminishes disease manifestations triggered by
diverse causes, ranging from the neural accumulation of amyloid proteins to mutations in genes encoding sodium
or potassium channels, stroke, and the pharmacological blockade of neurotransmitter receptors. Since all of
these abnormalities promote E/I imbalance and network hyperexcitability, which can disrupt important processes
required for the health of neurons and other brain cells, we hypothesize that the reduced E/I ratio in tau-deficient
brains explains, at least in good part, the broad therapeutic benefits of overall tau reduction. Here, we propose
to explore the underlying molecular mechanisms by combining cell type-specific tau ablation and chemically
induced E/I imbalance with molecular profiling analyses focused on excitatory forebrain neurons. Previous
studies have revealed that tau can bind to or interact with a plethora of other proteins. Because many, if not
most, of these tau-interacting proteins have the potential to affect neuronal activities, the primary mechanisms
by which tau enables and tau reduction counteracts network hyperexcitability remain to be determined. In light
of our recent discovery that selective ablation of tau in excitatory, but not inhibitory, neurons is sufficient to
counteract E/I imbalance, we hypothesize that these mechanisms can be revealed by comparing the molecular
profile of excitatory neurons that do or do not express tau before and during the emergence of chemically induced
network hyperexcitability. We propose to test this hypothesis at the mRNA level (Aim 1) and at the protein level
(Aim 2). Because of complementary strengths and weaknesses of these approaches and our related
experimental designs, we further hypothesize that an integrative analysis of the resulting datasets (Aim 3) has
the best chance to pinpoint the most critical mechanisms by which tau enables and tau reduction counteracts
the development of E/I imbalance under pathological conditions. Identifying these mechanisms could provide
new insights into the pathobiology of tau, help guide the development and evaluation of tau-targeting
therapeutics, and result in the identification of additional indications and drug targets.

Public health relevance
NARRATIVE Evidence for excitation/inhibition (E/I) imbalance of brain networks has been found in diverse disorders that are prevalent, devastating, and poorly responsive to available therapies, including Alzheimer’s disease, epilepsy, and autism spectrum disorders. Because eliminating the protein tau from excitatory neurons, which activate other neurons, blocks E/I imbalance in mouse models of these disorders, we will compare the molecular profile of excitatory neurons that do or do not produce tau, both before and during the emergence of chemically induced network hyperexcitability. The results of these analyses could reveal how tau contributes to brain disorders, help guide the development and evaluation of tau-targeting therapeutics, and result in the identification of novel drug targets.